Administration

The Administrative Core will be responsible for general administrative oversight and budgetary management of the program. Centralization of these activities will promote efficient management of the program's resources, and will significantly facilitate communication between Project and Core investigators. Dr. Baker, the Program Director, serves as director of this Core and she will have primary responsibility for the overall conduct of the Program Project. The Administrative Core will provide centralized secretarial support, which will assist with scheduling of monthly program meetings of Project Leaders, monthly presentations for the Program research teams, regular discussions and interactions with the Internal Advisory Committee, and yearly External Advisory Board visits, preparing quarterly and yearly financial reports and yearly progress reports, and coordinating administration of the sub-contract to Children's Hospital of Philadelphia. Dr. Baker will assist to ensure that the research performed through this Program Project is in compliance with NIH and Institution requirements

Public health relevance
This Core is responsible for the management of the overall Program Project. It provides the administrative structure and scientific leadership to maximize collaborative interactions and scientific exchange among Project Leaders, Core Leaders, and Internal and External Advisory Committees, as well as the necessary administrative and grants accounting support for the program project.